Adaptation and Implementation of an Evidence-Based Approach to Advance HIV Prevention and Care

ABSTRACT
Transgender women (TW) in Vietnam face cultural and societal pressure, stigma, isolation, and violence,
contributing to substance use, risky sexual behaviors, and suboptimal engagement in HIV prevention and care.
Despite these health disparities and adversities experienced by TW in Vietnam, there are no TW-specific
interventions designed to address their needs. TransAction is an evidence- and theory-based intervention,
developed by Dr. Cathy Reback (Co-Investigator) and TW in Los Angeles County, comprised of four core
elements: outreach, individual risk-reduction counseling sessions, skill-building and support groups, and social
events. TransAction participation is associated with increased self-efficacy and social support as well as
decreased HIV risks including engagement in exchange sex and substance use. TransAction is designed to be
delivered in resource-limited settings, so it is well-positioned to serve as an evidence-based HIV health
promotion intervention model for adaptation in Vietnam. Following the implementation science ADAPT-ITT
framework, researchers from the University of California, Los Angeles, Friends Research Institute, and the
University of Medicine and Pharmacy in Ho Chi Minh City (HCMC) have completed the first five steps
(Assessment, Decision, Adaptation, Production, Topical expert) of adapting TransAction for TW in Vietnam.
The four core elements of TransAction were deemed urgently needed while TW community members provided
valuable feedback on the adaptation and implementation of TransAction for Vietnamese cultural competency.
This R34 will build upon our strong existing U.S.-Vietnam and academic-community collaborative relationships
to complete the last three steps (Integration, Training, Testing) of the ADAPT-ITT process. In Phase 1, the
team will take a community participatory approach to work with TW community-based organizations (CBOs) to
develop TransAction protocols, materials, and health/social service navigation plans in the context of Vietnam.
TW peer facilitators will be identified and trained to deliver the intervention activities. In Phase 2, the adapted
TransAction will be pilot-tested with 80 HIV status-neutral TW aged 16 and above
from HCMC and adjacent
provinces with a two-arm, randomized design. TW in the intervention condition will participate in individual risk-
reduction counseling sessions and skill-building and support groups using an online/offline hybrid modality.
Both intervention and control groups will be invited to social events. Intervention outcomes, including
placement along the HIV prevention/care continua, multilevel/multifaceted stigma and coping, self-efficacy,
service utilization, HIV risks, and general health will be assessed at baseline, 3-, and 6-month. Implementation
outcomes, including feasibility, fidelity, and acceptability, will be evaluated based on data collected from
multiple sources.
This study will lay the foundation for a subsequent full-scale trial to evaluate the scalability,
efficacy, and sustainability of the culturally responsive HIV prevention and care intervention for TW in Vietnam
and other settings with limited trans-inclusive services.

Public health relevance
PROJECT NARRATIVE Transgender women (TW) are one of the key populations driving the HIV epidemic in Vietnam, yet there are no TW-specific interventions for Vietnamese TW with/at risk of HIV. Building upon our strong existing United States-Vietnam partnership and groundwork, this study will utilize implementation science methods to adapt and test the evidence- and theory-based U.S.-oriented TransAction intervention for TW in Vietnam. The flexible online/offline hybrid intervention model may provide valuable insights transferable to both other low- to middle-income countries and areas of the United States with limited trans-inclusive services.